Training in Areas Fundamental to Cancer Research

Project Summary/Abstract
This is an application for renewal of grant T32CA009110-42 to support the training of predoctoral students
and postdoctoral fellows in the conduct of research aimed at understanding the fundamental biochemical,
molecular and cellular processes underlying the development and progression of cancer. During the next funding
period, we are requesting continued support for 7 predoctoral and 3 postdoctoral trainees per year. The
administration of this program is centered in the Department of Biochemistry and Molecular Biology in the Johns
Hopkins University Bloomberg School of Public Health. However, training faculty associated with the program
represent 13 different departments across the Bloomberg School of Public Health and the Johns Hopkins
University School of Medicine, and include faculty affiliated with the Sidney Kimmel Comprehensive Cancer
Center (SKCCC). The addition of more than 25 new training faculty to the program over the past several years,
including 14 new additions with this renewal application, dramatically expands the opportunities available for
trainees to receive mentoring and training in productive, well-funded laboratories performing cutting edge cancer
research. Major research themes explored by training faculty affiliated with the program span a broad spectrum
of cancer biology including the tumor microenvironment, cell migration and metastasis, post-transcriptional and
epigenetic regulation of gene expression, and regulation of genome integrity. In addition to laboratory research,
all trainees are required to participate in cancer training courses offered by the SKCCC, as well as a cancer-
focused seminar series, journal club and monthly research colloquium, all designed to build core knowledge,
effective reasoning, and communication skills. Additionally, and as one of the unique aspects of this training
program, trainees receive instruction in the public health aspects of cancer research, in areas such as cancer
prevention and control, cancer epidemiology, and advocacy and awareness. Predoctoral students are admitted
to the program after demonstrating strong academic abilities and laboratory research potential during their first
year of training. Postdoctoral trainees showing strong substantiated interests in cancer research are selected
through a competitive review of applications. In this renewal application we aim to strengthen our commitment
to providing outstanding training through proposed changes to the curriculum that include enhanced training in
rigor, reproducibility and experimental design, quantitative sciences and biostatistics, and career planning. We
will also introduce formal training for faculty to develop mentoring skills and strengthen existing efforts to promote
diversity and inclusion. The program has a long history of attracting talented young trainees who remain active
in science and develop distinguished careers in cancer research. We aim to continue this tradition by equipping
trainees with the essential knowledge and skills needed for careers in cancer research, with a unique focus on
how this can both inform and be informed by public health practices.

Public health relevance
Project Narrative Cancer remains a major cause of human mortality and morbidity despite significant advances in diagnosis and treatment. This training program is designed to develop the next generation of independent cancer research scientists by providing them with essential fundamental knowledge, laboratory research skills, and leadership abilities needed to contribute to new discoveries in the prevention, early detection and treatment of cancer.